2023 Stochastic Physics in Biology GRC & GRS

Summary/Abstract
At the most fundamental level, physical and chemical laws such as thermodynamics and mass action govern
the operations of a living cell. At the functional level, however, when, where and at what rate a biomolecule
executes its function through its binding to a partner or its enzymatic actions is stochastic, and can only be
described in probabilistic instead of deterministic terms. At this level, the integration between experiments and
theories becomes extremely important, because new theories need to be developed to explain stochastic
experimental observations and guide further experimental explorations, and experiments need to be conducted
to test theoretical predications and establish biological significance. The importance of stochastic physics in
biology has been recognized by the growing research community and publications in premier journals. The
2023 GRC Stochastic Physics in Biology aims to bridge stochastic physical theories with biological
experiments by bringing together an outstanding and diverse group of physicists, mathematicians, engineers
and biologists at the forefront of research. It will address emerging challenges in understanding complex
behaviors of biological systems using principles and theories in stochastic physics. A carefully designed
conference plan with nine scientific sessions, four poster sessions, one Power Hour, and three social hours will
foster a stimulating environment for participants and serve as a vigorous intellectual hub for the growing
community. The conference will benefit the mission of NIBIB by providing a fertile scientific ground to
accelerate the application of biophysical and biomedical technologies to human health.

Public health relevance
Project Narrative The 2023 GRC is shaping up to be one of the most exciting and important meetings in the discipline, addressing emerging challenges in understanding complex behaviors of biological systems using principles and theories in stochastic physics. In particular, this meeting will focus on bridging stochastic physical theories with biological experiments by bringing together an outstanding and diverse group of physicists, mathematicians, engineers and biologists at the forefront of research. The meeting will make every attempt to encourage the participation of young scientists and students, especially scientists from underrepresented minority background. The conference pledges an all-inclusive scientific culture at the meeting.